Chinese Language Assessment in Primary Progressive Aphasia

PROJECT SUMMARY
Primary Progressive Aphasia (PPA) is a clinical syndrome characterized by isolated progressive loss speech
and language functions due to selective degeneration of language networks. Nearly all past PPA research has
focused on English language speakers, even though there are an estimated 1.2 billion native Chinese speakers
worldwide and 3.5 million Chinese speakers in the United States. Considering the comparable prevalence of
PPA in the Caucasians and Chinese-American population, there might be more than a million Chinese PPA
individuals worldwide. The majority of them remain unidentified or misdiagnosed, largely due to the lack of
appropriate assessment tools and lack of awareness. Chinese-speaking PPA individuals are mainly assessed
by speech and language tools translated verbatim from the English language. This is inadequate as it does not
account for the profound linguistics differences between English and Chinese language. Through the joint effort
of researchers, clinicians, and speech-language pathologists from the US, Taiwan, and Hong Kong, we
developed a neuroanatomically-based and linguistically-adapted Chinese language assessment battery for PPA
(CLAP). The CLAP battery's feasibility has been demonstrated through a pilot project funded by U.S. Alzheimer's
Association and Global Brain Health Institute.
The overarching goal of this project is to improve the clinical diagnosis and classification of Chinese-speaking
PPA patients. This project consists of two specific aims. The first aim focuses on validating the neuroanatomical
specificity of the individual tests in the CLAP battery. Through this effort, we will acquire in-depth anatomical
knowledge of various neurolinguistics components in the Chinese speaking population. The second aim is
designed to investigate the clinical and linguistics features of imaging-based phenotypes in our Chinese PPA
cohort. Enrolled Chinese-speaking PPA individuals will be clustered into different imaging-based phenotypes
based on their predominant atrophy areas. The MRI volumetric phenotypes will be compared between the
Chinese-speaking and English-speaking cohorts to validate the PPA neuroimaging signatures. The clinical and
linguistics features of each imaging based phenotype will be studied to identify significant key features that
facilitate the diagnosis and classification of the Chinese-speaking PPA population.
This project will provide novel mechanistic insights to the neural basis of language in Chinese speakers and
establish specific speech and language assessment tools for the Chinese-speaking PPA population with the
long-term goal of improving diagnosis and care for this underserved population. It also promotes linguistics
diversity in the field of neurodegenerative disease research.

Public health relevance
PROJECT NARRATIVE This research project focuses on the Chinese-speaking population that suffers from Primary Progressive Aphasia (PPA), a debilitating and fatal neurodegenerative disease that manifests predominantly with speech and language deficits. In this project, the University of California, San Francisco joints effort with Taiwan Buddhist Tzu Chi Medical Foundation to establish a Chinese-speaking PPA cohort with clinical, linguistic, and neuroimaging data. The proposed work aims to improve the clinical diagnosis of this currently underserved population and provide novel insights into the neural basis of speech and language and ultimately facilitate treatment development for this devastating disorder.